Building Research Capacity at Kairuki University to Study Oropharyngeal Complications Among HIV-Infected patients in Tanzania with the Goal of Improving Quality of Services and Quantity of Life

Project Abstract
This D71 Planning Application for Research Training will address gaps in knowledge of
the pathogenesis of HIV infection, HPV infection and associated clinical conditions in the
oropharynx and dental health among persons with HIV (PWH) in Dar es Salaam,
Tanzania. To date, research in low- and middle-income countries (LMIC) on these topics
is in its relative nascency, despite the common occurrence of oropharyngeal and dental
complications. In the preparation of this D71 application, we performed a scoping
literature review and found no publications on the intersection of oral health, HPV and
HIV in Tanzania. Among the partnering Institutions, Kairuki University (KU) will lead and
support consultants from the Muhimbili University of Health and Allied Sciences
(MUHAS), the Kilimanjaro Christian Medical University College (KCMU Co) and Duke
University (Duke), the planning process will address current gaps and expected scientific
opportunities, prioritizing these opportunities according to in-country needs, identifying
appropriate trainings to provide the needed research skills, and lead to the design of a
D43 research training program which will provide trainees with the research knowledge
and skills to fill the gaps. We will engage and leverage the HIV clinical science expertise
of KU, access to a large population of PWH and oropharyngeal and dental expertise of
the MUHAS School of Dentistry, and the scientific, clinical and training expertise of Duke,
MUHAS, and KCMUCo to create a portfolio of multidisciplinary training opportunities,
resulting in a highly competitive D43 application in 2025/2026. The D43 application will
ultimately enable KU to assemble an interdisciplinary expert research team to perform
state-of-the-art studies on HIV and its oropharyngeal and dental manifestations.

Public health relevance
Project Narrative The prevalence of HIV infection among citizens in the United Republic of Tanzania is 4.5%, representing a public health challenge of significant magnitude. HIV infection is frequently accompanied by dental and oropharyngeal complications, which are relatively understudied in low- and middle-income countries. This Planning Grant, led by Kairuki University in collaboration with partnering universities and key stakeholders, will assess the needs and opportunities to develop a training grant application to build a research team capable of addressing the gaps in knowledge and improve the health of Tanzanian persons living with HIV infection.